Transcriptional profiling of proliferative skeletal muscle mononucleated cells coupled with broadband electrical cytometry towards diagnosis of myalgic encephalomyelitis/chronic fatigue syndrome

Transcriptional profiling of proliferative skeletal muscle mononucleated cells coupled with broadband
electrical cytometry towards diagnosis of myalgic encephalomyelitis/chronic fatigue syndrome
PROJECT SUMMARY / ABSTRACT
Myalgic Encephalomyelitis/Chronic Fatigue Syndrome (ME/CFS) is a debilitating, acquired disease affecting up
to 2.5 million Americans. With increasing evidence that a proportion of patients with COVID-19 experience
prolonged convalescence and chronic symptoms similar to ME/CFS, it is suggested that the incidence of
ME/CFS will increase significantly. Currently, no single biomarkers or pathognomonic signs have been identified
for diagnostic measures. Instead, diagnosis is based on clinical symptoms after exclusion of other possible
etiologies known to cause fatigue, a method that does not prescribe adequate sensitivity or specificity. Since
clinical symptoms suggest that skeletal muscle is a major and consistent target of the pathology, and proliferative
skeletal mononucleated cells (SMMCs) are excellent indicators of muscle disorders, we hypothesize that
proliferative SMMCs from of ME/CFS patients are distinguishable from those of healthy individuals on the
molecular and cellular level. Proposed work will investigate gene expression, functional pathways and electrical
characteristics of single SMMCs from ME/CFS and healthy donors to identify a matrix of molecular and
biophysical markers to enable future development of diagnostics. Single-cell mRNA profiling will identify
differential gene expression describing alterations that occur in ME/CFS samples. Using differential biomarkers
identified by scRNA-seq, subpopulations of SMMCs unique to ME/CFS will be sorted to study changes in protein
expression and cell function. Furthermore, an impedance cytometer recently developed by our team will be used
to measure single cell electrical spectra, and disease-specific signatures will be identified by machine learning.
The molecular, cellular and electrical characteristics will be further correlated with each other to provide a
comprehensive understanding of the SMMC pathology in ME/CFS, an untapped subject. The proposed single-
cell transcriptome analysis of SMMCs from ME/CFS patients represents the first study of its kind and will greatly
contribute to the fundamental knowledge of the role of proliferative SMMCs in ME/CFS dysfunctions. Compared
to molecular approaches, proposed impedance cytometry captures a ‘big picture’ of the multitude of changes
contributing to abnormalities in ME/CFS SMMCs. As specific molecular markers have not been identified for
diagnostic measures, the holistic electrical characteristics of single cells offer a unique perspective of global
changes in SMMCs and hold great diagnostic potential in the future. Integration of electrical and biological studies
of SMMCs will further allow interpretation of the impedance spectra to promote sensing specificity.

Public health relevance
PROJECT NARATIVE Despite its prevalence, ME/CFS remains a poorly understood disease that lacks lab-based, objective diagnostic markers. We propose to study the gene expression, function and electrical property of donor derived, proliferative adult skeletal muscle mononucleated cells (SMMCs). The resulting electrical characteristics coupled with single cell genetic and biological studies have a potential to identify pathology and biomarkers in these cells for future development of ME/CFS diagnostics.